Training in Precision Environmental Health Sciences

PROGRAM SUMMARY / ABSTRACT
Precision Environmental Health uses “omics” technologies and data science to understand how our environment
influences human health and disease. The Training in Precision Environmental Health Sciences (TPEHS)
Program is designed to give the next generation of environmental health scientists the training needed to
advance their careers the field of Precision Environmental Health. TPEHS is a joint initiative of Baylor College
of Medicine, University of Texas (UT) Health Science Center Schools of Public Health and Biomedical
Informatics, and UT MD Anderson Cancer Center-the latter two new for this renewal, further expanding our
Program. These premier research-intensive institutions in the Texas Medical Center, the world’s largest medical
center, have joined together to address the need for a Precision Environmental Health workforce of tomorrow
with training at the intersection of Genomics/epigenomics, Environmental Health, and Data Science (GxExD).
TPEHS is at the vanguard of one of the leading environmental health sciences research communities in the
country. Our Program leverages multi-disciplinary research being conducted in the NIEHS P30 Gulf Coast
Center for Precision Environmental Health, P42 Superfund Research Center and NIMHD/NIEHS P50 Center of
Excellence in Environmental Health Disparities. TPEHS Program Objectives are for trainees to 1) acquire
fundamental knowledge in Genomics/epigenomics, Environmental Health, and Data Science; 2) become
proficient at integrating concepts of GxExD into their research; and 3) gain the necessary skills and tools to
leverage TPEHS training to achieve their career objectives. This T32 will provide stipends for 4 pre- and 3
post-doctoral trainees each year, matched by strong institutional commitments to support 4 additional
pre- and post-doctoral trainees, expanding our cohort size and increasing TPEHS impact and diversity. The
Core Curriculum for predoctoral trainees includes didactic coursework in Genetics/Epigenetics, Environmental
Health/Toxicology, Data Science, Responsible Conduct of Research, and training in Rigor and Reproducibility.
All TPEHS trainees take a required “Big Data Foundations” course and engage in structured Career
Development activities and networking opportunities. TPEHS has 42 well-funded training faculty, experienced
Program Director (PD) and Co-PDs representing all participating institutions, guided by Steering and External
Advisory Committees and trainee feedback, with administrative support provided by the Gulf Coast Consortia.
Our pool of applicants is robust and trainees diverse: 18% of T32-supported trainees are from underrepresented
groups, over half women and include those who seek (or have) PhD, MD, MD/PhD and MD/MPH degrees. Our
trainees have a strong cohort identity, and publish in both high-impact general interest and top-tier specialty
environmental health journals. At the end of the program, all TPEHS trainees have a deep understanding of
GxExD research, the skills needed to be effective Precision Environmental Health researchers and are
successful when they leave the program moving into careers in academia, medicine, and industry.

Public health relevance
PROJECT NARRATIVE The Training Program in Precision Environmental Health Sciences (TPEHS) is a joint initiative of Baylor College of Medicine, The University of Texas Health Science Center at Houston Schools of Public Health and of Biomedical Informatics, and The University of Texas MD Anderson Cancer Center. This multidisciplinary program provides the next generation of pre- and post-doctoral trainees the skills to be successful working at the intersection of Genomics/epigenomics, Environmental Health, and Data Science to improve our understanding of environment influences on human health and disease.